Nuclear Bodies: Hubs of Genomic Activity

Project Summary/Abstract
This application seeks support for a FASEB (Federation of American Societies of Experimental Biology)
Science Research Conference, entitled: “Nuclear Bodies: Hubs of Gene Expression.” The meeting will be
held July 24-28, 2024 at Niagara Falls, NY. This conference builds directly on momentum from a
predecessor FASEB meeting, held in 2022. Nuclear bodies are subcellular structures composed of
proteins and RNAs that typically occupy the spaces between interphase chromosomes. They have been
implicated in many aspects of gene expression at the post-transcriptional stages. Following the 2022
meeting, there has been increased attention on the relationship between nuclear bodies and human
disease, particularly cancer- and this topic will be a major focus of the meeting. In addition, the
biophysical phenomenon of liquid-liquid phase separation was found to be a major dynamic feature of
nuclear bodies and this will be a second major theme of the meeting. The program has 41 confirmed
speakers, of whom half did not attend the first meeting. As before, approximately one third of the
confirmed speakers are early career scientists (defined as graduate student, post-doctoral fellow or
Assistant Professor). The program includes a Keynote Lecture on Diversity, Equity and Inclusion in cell
biology, along with a Career Development and Mentoring session. Additional speaker invitations will be
made this autumn and subsequently from the submitted abstracts. The anticipated number of
participants is 75-80. The organizers will be approaching numerous companies and foundations for
additional support, together with funds being provided by FASEB, as described in the budget section of
the application. Similar to the 2022 meeting, a scientific report (FASEB J. 36(11):e2258. doi:
10.1096/fj.202201455R) on the conference will be published.

Public health relevance
Project Narrative This FASEB conference will address the emerging field of how gene expression is mediated by various molecular machines in the cell nucleus. Collectively termed nuclear bodies, these machines play key roles in the final production of transcripts destined either for translation into proteins or for regulatory roles within the nucleus. Research in this field has recently uncovered links between nuclear bodies and cancer, which will be a major focus of this meeting, including two Keynote Lectures and many other talks.